The Pathogenesis and Treatment of chronic GVHD

1) NIH BOS Montelukast trial (LAI): 19 patients enrolled to date. 14 patients have completed the primary endpoint. Interim analysis will be conducted after 20 patients (likely FY 2011) and analysis of immunological endpoints ongoing. 2) FHCRC new onset BOS trial (chair): submitted to NIH IRB (likely open in FY 2011), open at FHCRC. 3) Lung consortium trial: in development. 4) cGVHD myositis study of respiratory muscle: manuscript in submission. (completed, likely published in FY 2011). 5) AI ON CGVHD Natural history study. Manuscript on PFT function equations in submission (likely published in FY 2011).